Modeling Best Approaches for Cardiovascular Disease Prevention in Cancer Survivors

PROJECT SUMMARY
The overall goal of this proposal is to identify optimal strategies for primary prevention of cardiovascular
disease (CVD) for survivors of breast (BC), prostate (PC) and lung (LC) cancer. All together, there are >6
million BC, PC and LC survivors in the US. While cancer is a major source of morbidity and mortality, the
majority of BC and PC as well as many early-stage LC survivors die of comorbidities, particularly CVD. Cancer
survivors have increased rates of both CVD risk factors as well as CVD itself, and CVD is the leading cause of
death among BC and PC survivors. Among LC survivors, CVD-related deaths account for ~30% of mortality;
this proportion is higher among the growing number identified with early-stage LC. In the general population,
primary prevention with lipid-lowering agents (i.e., statins) and aspirin is highly effective for decreasing CVD
incidence and mortality, but these guidelines for primary CVD prevention cannot be extrapolated to cancer
survivors. Approaches for CVD prevention in cancer survivors need to consider traditional risk factors
(including genetic risks) for CVD as well as CVD risk from certain cancer treatments. Additionally, competing
risks from cancer recurrence or comorbidities may limit the long-term benefits of primary CVD prevention.
Finally, the cancer itself, cancer treatment-related complications, and a higher prevalence of comorbidities can
negatively impact quality-of-life and attenuate the absolute improvement in quality-adjusted life expectancy and
the cost effectiveness (CE) of primary CVD prevention. Lack of specific data applicable to cancer survivors has
profound negative impact, resulting in worse cardiovascular outcomes. It is unlikely that randomized controlled
trials (RCT) assessing the benefits of CVD preventive strategies for cancer survivors will be ever conducted.
Thus, there is an urgent need to use alternative methods to optimize preventive care recommendations for this
growing population. We propose using simulation modeling, an approach complementary to clinical trials, to
assess the harms, benefits, and CE of CVD prevention in diverse populations of cancer survivors. The Specific
Aims are to: (1) Develop an Integrated Multi-Ethnic Cancer model (IMEC) to incorporate the development,
progression, and outcomes of CVD among a diverse population of BC, PC and LC survivors; (2) Identify BC
survivors who will benefit from and determine the CE of primary CVD prevention; (3) Determine effectiveness
and CE of primary CVD prevention in PC survivors; and (4) Determine the most effective and CE CVD
prevention strategies for LC survivors. To achieve these Aims, we will use data from several large, diverse and
nationally representative, population-based cancer and cardiovascular cohorts to create, calibrate, and validate
IMEC (Aim 1). Then, we will use the model to test our hypothesis by conducting in-silico RCTs (Aims 2-4). Our
study is innovative in using state-of-the-art modeling methods and novel data harmonization, statistical and
simulation approaches to optimize the use of CVD preventive strategies in cancer survivors. The results will
have direct implications for the management of large numbers of survivors and guide patient decision-making.

Public health relevance
PROJECT NARRATIVE The goal of this proposal is to identify optimal strategies for primary prevention of cardiovascular disease (CVD) for survivors of breast (BC), prostate (PC) and lung (LC) cancer by developing and validating a novel Integrated Multi-Ethnic Cancer model (IMEC) to incorporate the development, progression, and outcomes of CVD among a diverse population of BC, PC and LC survivors. We will then assess the effectiveness and cost- effectiveness (CE) of different primary CVD prevention strategies for this large group of cancer survivors (>6 million in the US). The study will be innovative in applying state-of-the-art modeling approaches to evaluate primary CVD prevention strategies in a diverse population of cancer survivors, an understudied group at risk for poorer outcomes, and our results will have direct implications for the management of large numbers of cancer survivors and guide patient decision-making.